ASSESSMENT OF RETINAL CIRCULATION IN PREMATURE AND TERM INFANTS

To study retinal blood flow in infants with ROP in order to predict disease regression or further development of disease using Laser Doppler Velocimetry.